Texas Occupational Safety and Health Surveillance- Fundamental Program

PROJECT SUMMARY
State-based occupational safety and health surveillance systems are essential for tracking
occupational exposures, injuries and illnesses, identifying emerging issues and priority/high-risk
worker populations for preventive interventions. The Environmental Surveillance and Toxicology
Branch (ESTB) at Texas Department of State Health Services (DSHS) requests five years of
funding for an Expanded Program under the National Institute for Occupational Safety and
Health (NIOSH) State Occupational Safety and Health Surveillance Program. As part of
enhanced fundamental program activities, we will collect, analyze and report data for all
currently-defined occupational health indicators (OHI) by the Council of State and Territorial
Epidemiologists, conduct detailed analysis of OHIs and other state and national datasets. We
will also conduct in-depth investigation and case follow-up activities for adult blood lead
epidemiology and surveillance (ABLES). DSHS also proposes three expanded projects- 1)
acute occupational pesticide poisoning (AOPP) surveillance and prevention, 2) occupational
respiratory disease (ORD) surveillance and prevention and 3) enhancing state’s occupational
health informatics for emergency preparedness and response. We will continue collaborative-
enhancing activities with state and federal partners to conduct interventions for prevention of
injuries and illnesses. Improved surveillance, data dissemination and targeted preventive
interventions for high-risk, high-priority occupational health issues and conditions will lead to
decreased occupational mortality and morbidity, eventually overall improvements in population
health.

Public health relevance
PROJECT NARRATIVE States can provide data from case- and population-based surveillance and in-depth investigations of occupational injuries and illnesses and contribute to the national occupational safety health surveillance efforts. These data can help guide targeted intervention efforts to reduce and prevent work-related mortality and morbidity. Given more than 50% of Texas residents are employed, this will lead to overall improvement in population health.